Developmental Research Program

PROJECT SUMMARY– DEVELOPMENTAL RESEARCH PROGRAM (DRP)
The objective of the SPORE Developmental Research Program (DRP) is to identify and support exciting
prostate cancer research and ensure a continuous renewal of high-quality scientific endeavors within the
SPORE. The program will recruit diverse disciplines and backgrounds to bring fresh ideas and new
approaches to prostate cancer. The DRP will also create opportunities that support the recruitment and
retention of women and underrepresented racial and ethnic groups in the field. Applications will be solicited
broadly and reviewed fairly by a highly qualified and engaged committee. DRP recipients will become part of
the SPORE community with exposure, feedback, and access to core resources. Progress will be monitored,
and recipients will be helped and encouraged to apply for other funding opportunities. Overall, the DRP will
maximize the chance that new and cutting-edge concepts supported by promising pilot data have the
capability to receive larger grant funding and ultimately impact the field. This will be achieved through the
following specific aims: 1) Foster the development of innovative and promising prostate cancer research by
providing seed funding to the highest rated projects solicited from RFAs; 2) Identify and prioritize
solicitations focused on areas of with the potential to have the highest impact of improving the outcome of
patients with prostate cancer, with a specific focus on underrepresented racial and ethnic groups; 3) Monitor
the progress of developmental projects, provide critical and timely feedback, and encourage and enable
promising DRP projects to compete for extramural peer- reviewed funding. When necessary and promising,
promote the most meritorious DRP projects to full SPORE research projects; 4) Bring new investigators into
prostate cancer translational research with specific efforts to recruit females and investigators from under-
represented racial and ethnic groups.